Lung Cancer Early Detection and Immunotherapy Response Prediction and Monitoring with an Exo-PROS Liquid Biopsy Assay

PROJECT SUMMARY
Lung cancer causes about 25% of all cancer deaths worldwide. Early detection and effective treatment are
critical in reducing the mortality. Low-dose computed tomography (CT) is the recommended screening test for
lung cancer, however, its high false-positive rate leads to unnecessary biopsy and repeated radiation
exposure. Immune checkpoint inhibitors (ICIs) have revolutionized treatment for lung cancer, however, they
are only effective for a minority of patients. Predicting and monitoring responses to ICIs by tissue biopsy and
imaging are limited by invasive procedure, the lack of effective tumor biomarkers, pseudo progression, and
delayed response. Therefore, non-invasive, accurate and affordable methods are urgently needed to detect
lung cancer early and to effectively predict and monitor response to ICIs, aiding in improving patient outcomes.
Liquid biopsy detects tumor-derived biomarkers in body fluids such as blood, complements imaging and risk
factor data, allows sequential monitoring of cancer development, and thus represents a new and non-invasive
strategy to address these unmet needs. Exosomes are nano-sized extracellular vesicles secreted by cells.
They are actively involved in every step of cancer development and have emerged as promising cancer
biomarkers. We hypothesize that tumor-derived exosomes (TEXs) are highly sensitive and specific for lung
cancer early detection and treatment response prediction and monitoring, and the combination of TEX markers
provides superior diagnostic and predictive performances than single markers alone.
A major challenge in developing exosomes-based cancer biomarkers is the separation of TEXs from
exosomes released by normal cells, the latter of which can render the test less sensitive or incapable of
detecting TEX biomarkers. To overcome this challenge, we have developed an exosome protein RNA one stop
(Exo-PROS) biosensor. The Exo-PROS assay first selectively captures TEXs from non-TEXs using cancer-
overexpressed markers, and then, for the first time, provides one-stop and in-situ quantitation of three types of
TEX biomarkers including proteins, microRNAs and carbohydrate antigens. In our pilot study, we demonstrated
that combined TEX biomarkers (EGFR, miR-21, LG3BP, miR-210, TF-Ag-α) distinguished lung cancer from
normal controls with sensitivity of 1.00 and specificity of 1.00. We also showed that TEX PD-L1, miR-21 and
TF-Ag-α successfully predicted the response to anti-PD-1 therapy in lung cancer patients. In this project, we
will (1) further develop the Exo-PROS assay and characterize its analytical performances including sensitivity,
specificity, linear range and repeatability; (2) determine the diagnostic values of Exo-PROS assay in lung
cancer early detection and demonstrate that Exo-PROS assay complements low dose CT and improves the
diagnostic accuracy; (3) evaluate Exo-PROS assay in predicting and monitoring response to anti-PD-1
therapy, and demonstrate that Exo-PROS assay is an effective test to complement tissue biopsy and imaging
modalities in clinical decision making and patient care.

Public health relevance
PROJECT NARRATIVE Current screening and diagnostic tests for lung cancer such as low dose CT and tissue biopsy are limited by high false positive rate, radiation exposure and invasive procedure. Liquid biopsy detects tumor-derived biomarkers in blood, allows sequential sampling, complements medical imaging and risk factor data, and thus represents a new and non-invasive strategy to address these challenges. We propose to develop an accurate, simple, fast, user-friendly and cost-effective liquid biopsy test, i.e., the Exo-PROS assay, to sensitively and simultaneously detect multiple types of biomarkers in tumor-derived exosomes for lung cancer early detection and immunotherapy response prediction and monitoring.